Epithelial Cell Reintegration in Development and Disease

PROJECT SUMMARY
Many epithelial tissues are two-dimensional sheets of cells. Recent work from multiple
systems shows that a misplaced epithelial cell can reintegrate back into the sheet, and
suggest that this process is a common feature of tissue development. We aim to
understand this process. Our previous work in the fruit fly Drosophila melanogaster
showed that cell reintegration fails in the absence of homophilic adhesion molecules that
line cell-cell borders. This observation raises the question of whether the same
molecules mediate reintegration in other systems. Our preliminary work also suggests
that these molecules coordinate with other structural components to remodel the cell
after division, and that it is this process that drives reintegration. We propose three
specific aims: 1) Determine whether lateral adhesion mediates reintegration in three-
dimensional cultured vertebrate tissue systems. 2A) Find out whether reintegration
requires cooperation between adhesion molecules and cytoskeletal components. 2B)
Establish whether reintegrative capacity is limited to newly-born cells. This work will
illuminate cell reintegration, a fundamental property of epithelial tissues, and help to
explain its importance to tissue development and maintenance.

Public health relevance
PROJECT NARRATIVE Epithelial tissues are sheets of cells that line our body cavities, where they usually serve as barriers to the external environment. Recent studies show that these sheets are surprisingly resilient, since cells located outside of the tissue can move back into it. This project aims to discover how the reintegration process works, and provide a basis for understanding how reintegration failure can disrupt tissue function and contribute to disease.